Research Training in Pediatric Urology/CHB T32

Project Summary
This is a competitive renewal application for a National Research Service Award (NRSA) Institutional
Training grant (T32) for research training in pediatric urology at Boston Children's Hospital. For the past 14
years, this funding mechanism has supported the research component of our pediatric urology fellowship
program. The pediatric urology fellowship at Boston Children's Hospital is the oldest and one of the most
highly regarded such programs in the world. The Urology Department at BCH is one of the world's leading
centers for pediatric urology and genitourinary reconstruction and has one of the largest research programs
dedicated to basic urology research in the country.
The overall goals of the training program are: (1) to teach state-of-the-art, hypothesis-driven, modern
research methodology relevant to both basic science and clinical research; (2) to provide sufficient time
and guidance for a mature postdoctoral experience in basic, translational or clinical studies relevant to the
trainees' future clinical careers and academic leadership roles; (3) to provide trainees' with tangible skills in
scientific writing, mentoring, personnel management and leadership to facilitate their transition to
independent careers as clinician-scientists; and (4) to facilitate funding through career development and
investigator-initiated grants. In the most recent funding cycle, postdoctoral MD trainees who have
completed urology residency have conducted research in laboratory-based studies of urogenital tract
development, physiology and pathophysiology. Training in clinical outcomes and health services research
is also available in conjunction with faculty at the Harvard T.H. Chan School of Public Health. Trainees also
undergo didactic training in critical thinking and grant writing, biostatistics and the responsible conduct of
research. Two postdoctoral positions are requested per year for 2 years of research training. Twenty
preceptors and 8 clinical preceptors comprising basic science and clinical faculty from 7 programs will
support the training program.
The fellowship represents a unique combination of outstanding basic, translational and clinical research
training within one of the world's leading centers for academic medicine and biomedical science. It is
designed to enable our graduates to establish their own competitive programs of scholarship and research
during their careers as academic pediatric urologists. We anticipate these clinician-scientists will become
leaders in academic urology through contributions to understanding the genitourinary system in
fundamental terms, to translating basic research findings into clinical applications and to understanding the
implications of new discoveries for patient care. The T32 Pediatric Urology Research Training mechanism
is the major source of support for the fellows during the research component of their fellowship.

Public health relevance
Narrative The overall goal of the training program in pediatric urology is to provide a comprehensive, mentored training experience for clinicians in a rich and stimulating environment, and to train them in state-of-the-art basic science and clinical research methodology. At the end of the fellowship, graduates will emerge with skills that will enable them to establish their own competitive programs of scholarship and research during their careers as academic pediatric urologists. We anticipate these clinician-scientists will become leaders in academic urology through contributions to understanding the genitourinary system in fundamental terms, to translating basic research findings into clinical applications and to understanding the implications of new discoveries for patient care.